Physical mechanisms of cell rearrangements during germband extension in Drosophila melanogaster

A major question in developmental biology is how tissues and organs acquire their shape
through the process of morphogenesis. Basic considerations from mechanics imply that tissues
are shaped by dynamical changes in (1) cellular forces and (2) tissue material properties. The
predominant approach to morphogenesis has consisted largely of genetics and imaging, neither
of which is sufficient to quantitatively determine either the forces or tissue properties. Here we
propose to measure material tissue properties directly, using calibrated micro-cantilevers to
probe tissue with subcellular resolution, in combination with lightsheet microscopy to quantify
deformations. From a comprehensive map of material properties and cellular dynamics, we will
be able to computationally infer the pattern of forces driving these dynamics uniquely. Using
Drosophila germband extension as a model, we will apply our approach to determine the
physical mechanisms underlying cell intercalation, rosette formation and resolution, and tissue
elongation. Our methods are in principle applicable to any developmental system.

Public health relevance
The shape of animal tissues and organs is critical for their function, but the generation of shape is poorly understood. One of the major limitations has been a lack of technology to probe the underlying physics that drives tissue morphogenesis. Here, we propose a technique combining lightsheet microscopy and micromechanical manipulations to measure the mechanical properties of cells in a developing tissue.